Regulation of the DNA Damage Response

PROJECT SUMMARY
Numerous environmental and cellular factors can induce DNA lesions or create other types of challenges that
can slow DNA replication, leading to replication stress. Failure to alleviate this stress and restart stalled replica-
tion forks can cause genome instability, which can drive cancer initiation and progression and affect the cellular
response to chemotherapy. Hence, deciphering the cellular response to replication stress––the long-term goal
of this application––is imperative for understanding fundamental aspects of tumorigenesis. One crucial aspect
of the replication stress response involves replication fork reversal, a process that leads to the formation of a
four-way junction structure by the remodeling of both nascent and parental DNA strands. There are a family of
ATP-dependent translocases that promote fork reversal in vitro and in cells, but why so many translocases are
involved in this process is not understood. We showed that one of these translocases, HLTF, prevents a
stress-resistant mode of replication by promoting fork reversal, and we elucidated the basic mechanism by
which cells continue replication upon HLTF loss. The overall goal of the proposed project is to further elucidate
the mechanisms by which HLTF mediates the replication stress response, characterizing its unique role in this
process. HLTF is a multi-functional protein and recent studies using a panel of HLTF mutants that are each
deficient for one of its activities have revealed unexpected roles for these activities in HLTF’s known functions,
raising a number of new and exciting questions. This application will address questions about the molecular
mechanisms by which HLTF promotes fork slowing and fork reversal in cells and determine the impact of its
loss on replisome stability, genome stability, and cell proliferation. Aim 1 will investigate which domains of
HLTF are needed for fork slowing, fork reversal, and resistance to replication stress, and HLTF’s association
with the replication fork. HLTF’s dynamic interaction with the fork will also be probed. Aim 2 will investigate a
newly discovered function for HLTF in stabilizing the replication fork. These experiments will employ a combi-
nation of molecular, cellular, genetic and proteomic approaches as well as single-molecule imaging and track-
ing methods in Xenopus extracts to solve fundamental questions about how cells respond to replication stress.

Public health relevance
PROJECT NARRATIVE Healthy cells have numerous safeguards to slow or halt replication when faced with DNA damage or other forms of cellular stress. Many cancers, however, have the remarkable ability to tolerate high levels of DNA damage and other replication challenges imposed by environmental and endogenous agents, often at the cost of more mutations. Understanding the mechanisms by which cells respond to replication stress can help reveal how cancer cells can accumulate mutations and become drug resistant, which may ultimately lead to new therapeutic approaches to this disease.